Cardiovascular risk prediction from small, low-densitycalcifications detected on CT calciumscore exams

Abstract
Atherosclerotic cardiovascular disease continues to be a significant health concern worldwide. Improving risk
stratification is particularly crucial to identify individuals at risk for near term cardiovascular incidents and detect
disease earlier. Using cardiac CT scans for coronary artery calcium (CAC) scoring is a well-established risk
assessment method, but the traditional Agatston calcium scoring method lacks sensitivity for near-term and
early-stage disease detection. On cardiac CT images, small, low-density, “spotty” calcifications have been linked
to high-risk plaque characteristics, like inflammation and stress, and signal an early stage of atherosclerosis
before progressing into larger calcifications. Yet, these small calcifications are usually overlooked in standard
Agatston scoring due to their low density and/or small size. The objective of the proposed research is to apply
advanced computational methods like deep learning to optimize the detection of these “sub-Agatston”
calcifications (Sub-Aim 1a) and derive reliable image features that characterize these sub-Agatston CACs and
are predictive of cardiovascular risk (Sub-Aim 1b). To gain insights into the mechanisms of atherosclerosis
initiation and progression, sub-Agatston calcification features will be causally associated with potential drivers of
atherosclerosis, including socioeconomic, clinical, and image-derived-metabolic risk factors (pericoronary and
epicardial adipose tissue) (Sub-Aim 2a). Lastly, the predictive value of sub-Agatston calcifications for major
adverse cardiac events will be assessed in over 100,000 patients through Cox proportional hazards modeling
(Sub-Aim 2b). This proposed research will yield: (1) Improved risk prediction models accounting for new (sub-
Agatston) and understudied features (socioeconomic status). (2) New insights into atherosclerosis onset and
progression (3) Technical innovations in machine learning and causal inference for medical imaging. (4)
Translational software tools suitable for clinical risk assessment. This proposal, levering big CT data analytics,
will provide crucial knowledge on the prognostic value of small, low-density calcifications detected on CT images,
advance preventative cardiovascular medicine through the early detection of heart disease, and enable a new
understanding of atherosclerosis initiation and progression.

Public health relevance
Project Narrative This project aims to improve the early detection of heart disease by using advanced computational methods to detect small, low-density coronary calcifications in CT calcium score exams, a fast, inexpensive, image-based screening exam. These tiny calcifications are linked to “vulnerable” plaques, which can cause heart attacks, especially in younger individuals. Identifying these small calcifications can improve early heart disease detection and guide precision preventative therapies, ultimately reducing deaths from heart disease.